Utilization of a novel dissimilarity approach to identify a novel mechanism of Merkel cell polyomavirus small tumor antigen nuclear import responsible for the development of Merkel cell carcinoma

Project Abstract
Merkel Cell Carcinoma (MCC) is a rare but aggressive skin cancer with a mortality rate three times higher than
melanoma. Treatment for MCC remains a challenge, with only approximately 50% of individuals responding to
current therapies. Notably, 80% of MCC cases are caused by Merkel Cell Polyomavirus (MCPyV); understand-
ing the mechanisms of MCPyV tumorigenesis is thus of critical importance for the development of effective
therapies for MCC. In MCPyV-positive MCC, the small (ST) and large (LT) tumor antigens are responsible for
the development of MCC. MCPyV belongs to a family of 15 human polyomaviruses (HPyV), all of which encode
their own ST and LT; however, only MCPyV is associated with cancer. Seeing the lack of other oncogenic
HPyVs for comparison as a limitation, earlier research has focused on the similarities between MCPyV and two
oncogenic, non-human polyomaviruses (Simian Virus 40 [SV40] and Murine Polyomavirus [MuPyV]). How-
ever, this approach has been limited by MCPyV, SV40, and MuPyV each utilizing a different tumor antigen as
their dominant transforming protein: ST is the dominant transforming protein of MCPyV but is only an acces-
sory player in SV40- and MuPyV- mediated transformation. Instead, this project uses an innovative “dissimi-
larity approach” to exploit the fact that MCPyV is uniquely tumorigenic among HPyVs. By identifying the dif-
ferences between MCPyV and two skin-tropic, non-oncogenic HPyVs, Trichodysplasia Spinulosa Polyomavirus
(TSPyV) and Human Polyomavirus 7 (HPyV7), one could identify the unique mechanisms responsible for
MCPyV oncogenesis. Using this approach, it was found that MCPyV ST is uniquely capable of nuclear localiza-
tion despite the absence of a nuclear localization signal (NLS) and that nuclear localization was necessary for
cellular transformation. To further investigate MCPyV ST nuclear localization and its role in the unique trans-
formative capabilities of MCPyV ST, the following aims are proposed. The first aim seeks to identify the MCPyV
ST novel NLS (nvNLS) by focusing on a region of 30 amino acids (MST30) responsible for nuclear localization.
The second aim will determine whether the nvNLS is responsible for the unique transforming abilities of
MCPyV ST among HPyVs and will facilitate understanding of the HPyV determinants in inducing malignant or
non-malignant disease. The third aim seeks to further understand the mechanism by which MCPyV ST can ac-
complish nuclear import by investigating interactions with nuclear transport proteins such as importin and nu-
clear pore complex proteins. Together, the aims investigated in this proposal will further our understanding of
cellular nuclear import, determinants of HPyV oncogenesis, and the mechanisms of MCPyV ST-induced MCC,
which may collectively prove influential in developing novel, efficacious therapies for MCC. All aspects of these
investigations will be performed by Stetson University undergraduate students, thereby providing students
with invaluable biomedical research experience, and strengthening the research culture of Stetson University.

Public health relevance
Project Narrative The proposed research develops innovative methods to identify mechanisms by which viruses cause cancer. Successful completion of this project has the potential to reveal previously unknown mechanisms of viral oncogenesis that will facilitate the development of novel, efficacious therapies to improve patient outcomes and survival, especially in aggressive viral-associated cancers that resist current treatment protocols. This research also has the potential to increase our understanding of the general pathways involved in cellular transformation and thus also improve treatments for non-infectious cancers.